Research Tested Intervention Programs/National Registry of Evidence-based Program

The purpose of this Agreement is to set forth the terms of the continuing relationship between the National Cancer Institute (NCI), National Institutes of Health (NIH) and the Substance Abuse and Mental Health Services Administration (SAMHSA), for the management and execution of identifying, reviewing and rating NCI-funded cancer control intervention programs through the National Registry of Evidence-based Programs and Practices (NREPP). In April 2003, NCI launched a new website titled Research Tested Intervention Programs for Cancer Prevention and Control. This website allows cancer control planners, program staff and researchers to access and acquire evidence-based cancer control programs and products. A feature of this website allows viewing a Consumer Reports style rating of the research integrity, intervention impact, dissemination capability, and Re-AIM criteria.